Using Multiphase Optimization Strategy (MOST) to Optimize a Cost-effective, Sustainable and Scalable Smoking Cessation Package for Smokers in HIV Clinical Care

Project Summary
The adverse health impact of cigarette smoking on persons living with HIV is profound and effective treatments
for long-term abstinence remain elusive. There is an acute need for interventions that address patient barriers
to quitting and clinical barriers to effectively treating a broad heterogeneous population of smokers living with
HIV (SLWH). This study’s long-term goal is to improve clinical outcomes among SLWH by providing optimized
smoking cessation interventions in HIV clinical care. This proposal will use the Multiphase Optimization STrategy
(MOST) to test four intervention components aimed at barriers to quitting among SLWH, with the objective of
selecting the set that constitutes a cost-effective, sustainable, scalable smoking cessation package for HIV
clinical care. Components include: Motivational Interviewing (Off/On); Peer Mentoring (Off/On); Text-messaging
(Off/On); Varenicline or Combination Nicotine Replacement Therapy (Off/On). These components have shown
promise in research but are under-utilized to help SLWH quit and have not been tested in an optimization trial.
The proposed MOST factorial optimization trial is a highly efficient method for estimating the main effect
contribution of each intervention component and all interactions between components. This approach addresses
weaknesses in prior studies, which are not able to assess the contribution of individual components of
multicomponent interventions. The proposal will also include a rigorous evaluation of the implementation process
and theory-driven assessment of barriers to and facilitators of intervention implementation, sustainability and
scalability in HIV clinical care. Aims include: (1) Assess the effectiveness of four smoking cessation intervention
components on long-term abstinence among SLWH by conducting a highly efficient factorial optimization trial
(i.e., MOST) with 500 SLWH in HIV clinical care. (2) Assess costs and the implementation process, including
factors that affect the potential for sustainability and scalability of cessation treatment in HIV care settings serving
SLWH. Guided by Proctor’s Implementation Outcomes Framework and the Consolidated Framework for
Implementation Research, we will collect mixed methods data on reach, fidelity, acceptability and
appropriateness among SLWH, stakeholders and study interventionists. (3) Identify the optimized intervention
by conducting an innovative multi-criteria decision analysis to select the subset of the four components that
achieves the highest level of cost-effectiveness and is both scalable and sustainable in HIV clinical care. Working
in collaboration with New York City Health and Hospitals (H+H), the largest municipal public healthcare system
in the U.S., and a team with unparalleled expertise in intervention optimization, smoking cessation and HIV/AIDS,
the proposed study responds directly to the National Cancer Institute’s (NCI) call for smoking research that
“optimizes intervention effectiveness, implementation and sustainability.” The optimized intervention will have a
significant public health impact and add to scientific knowledge by providing a clear basis for further improvement
of cessation interventions for SLWH in future research.

Public health relevance
Project Narrative This study will utilize Multiphase Optimization Strategy (MOST) to optimize smoking cessation treatment for HIV clinical care by directly targeting patient barriers to quitting and clinical care barriers to reaching and effectively treating a broad heterogeneous population of smokers living with HIV. Given that over 75% of the 1.2 million persons living with HIV in the U.S. receive HIV clinical care annually, the results of this study will have a significant public health impact by optimizing a cost-effective, sustainable and immediately scalable smoking cessation package tailored specifically for the HIV clinical care context. Findings will also add to scientific knowledge by providing a clear basis for further improvement of cessation interventions for smokers living with HIV.